Project 3: Analysis of intrinsic and extrinsic factors that promote prostate neuroendocrine differentiation

Project Summary/Abstract
The clinical use of potent anti-androgens has promoted the emergence of novel forms of castration-
resistant prostate cancer (CRPC), including neuroendocrine prostate cancer (NEPC), which is highly aggressive
and lethal. To date, relatively little is known about the regulatory programs for specification of rare
neuroendocrine cells in the normal prostate, or how they might be recapitulated or altered during neuroendocrine
differentiation in prostate cancer. Therefore, we will pursue a comparative analysis of neuroendocrine
specification in the normal and transformed prostate to elucidate similarities and differences in their regulatory
programs. In preliminary studies of prostate organogenesis, our findings suggest that prostate neuroendocrine
cells are generated at pre-pubertal stages of organogenesis, when androgen levels are low, and that the
transcription factor Ascl1 is essential for formation of prostate neuroendocrine cells. To complement these
analyses, we have also performed studies of neuroendocrine differentiation in prostate tumors through single-
cell RNA-sequencing of mouse CRPC tumors and organoid models to identify candidate non-cell autonomous
interactions that may regulate neuroendocrine differentiation, as well as computational analyses to identify novel
candidate master regulators of neuroendocrine differentiation in tumors. Importantly, we have obtained evidence
for a non-cell autonomous role for extrinsic signals from the microenvironment in promoting neuroendocrine
differentiation of prostate tumor cells.
Based on our preliminary data, we hypothesize that neuroendocrine differentiation in both normal and
tumor contexts is governed by extrinsic signals from the environment in response to low AR activity in order to
regulate intrinsic pathways of neuroendocrine specification. To investigate this hypothesis, we will pursue an
innovative combination of in vivo, ex vivo, molecular, and computational analyses that are organized in three
synergistic specific aims: (1) Investigation of Ascl1 in prostate development and cancer to pursue comparative
analyses of its role in normal and tumor contexts; (2) Investigation of intrinsic regulators of neuroendocrine
differentiation in prostate cancer using computational systems approaches to identify candidate master
regulators followed by their functional validation; and (3) Analysis of stromal signals that promote neuroendocrine
differentiation in response to androgen deprivation to evaluate the role of candidate signaling factors from the
microenvironment in modulating neuroendocrine differentiation in response to AR in organogenesis and prostate
cancer. These studies will have strong translational impact through the identification of molecular targets that
are specific for neuroendocrine prostate cancer. Furthermore, this project will be highly integrated with the other
components of this program project through collaborative interactions with the Sawyers lab in analyzing
microenvironmental signals, with the Abate-Shen lab in studies of mouse models, with Core A in analysis of
human tissue samples, and Core B for statistical support and data management,

Public health relevance
Project Narrative Our proposed studies are highly significant at the translational level since neuroendocrine differentiation represents a common mechanism of treatment resistance for castration-resistant prostate cancer. We will pursue a comprehensive analysis of neuroendocrine differentiation in both development and cancer to provide a unique perspective for delineating the molecular mechanisms of treatment-induced transdifferentiation in prostate tumors. Our analyses should identify molecular targets that are specific for neuroendocrine prostate cancer, which can be utilized to block the emergence of this highly lethal disease.